Research Resource for Human Organs and Tissues (U42)

The Human Tissue and Organ Research Resource (HTORR) is a division of the National Disease
Research Interchange (NDRI), the only not-for-profit NIH-funded organization whose mission is
to provide the biomedical research community with human tissues for research. NDRI has a
unique 24/7 nationwide human tissue acquisition network of over 130 tissue source sites,
including organ procurement organizations, tissue banks, eye banks, hospitals and individual
donors registered with the NDRI private donor program. HTORR is an essential research
resource that uses systems customized to meet individual researcher requests to recover and
distribute a broad range of high quality normal and diseased human tissues recovered from a
diverse donor pool. HTORR, will continue to enhance researcher service and meet the evolving
and expanding needs of the research community through 1) Supporting HTORR’s service to the
biomedical research community by providing customized customer service, improving the quality
of human tissue collection, and enhancing communication to the biomedical research community
2) Providing HTORR with a Tissue Source Site (TSS) network to meet the changing needs of the
scientific community by monitoring TSS performance against demand, providing TSS with the
tools necessary for donor screening and tissue recovery, and collaborating with additional
partners to access tissue from donors with specific diseases, and 3) Continuing to monitor and
maintain adherence to laws, regulations, industry best practices, and standards regarding the
donation of human tissue for research. In addition to the serving researchers studying a wide
range of common diseases, HTORR will continue to provide human tissues to investigators
studying rare diseases, including LAM, and HIV. Implementation of this plan will ensure
uninterrupted service of high quality, well annotated normal and diseased human biospecimens
to investigators from an established network of tissue source sites, in concert with the
development and implementation of innovative project-focused initiatives designed to meet the
evolving needs of the biomedical research community.

Public health relevance
Project Narrative The research demand for human tissues continues to grow and the HTORR program provides a unique service to biomedical investigators nationwide whose research requires human tissues, organs and well annotated data. Over the past 4 years nearly 500 scientific papers were published by scientists who used HTORR-provided tissues, confirming HTORR's indispensable contribution to the biomedical research community and the impact of these services on the search for new treatments and cures for common and rare diseases, including HIV/AIDS.